Alleviating age-related memory impairment through proteasome stimulation

Project Summary/Abstract
Aging is characterized by a general decline in cognitive abilities, including the ability to accurately form and recall
episodic memories. Age-related memory impairments affect nearly 25% of U.S. adults over the age of 65 and
constitute a significant risk factor for the development of Alzheimer's disease (AD). The emotional and financial
burden of aging on caregivers, family, and taxpayers is substantial and growing, as the projected percentage of
the population of individuals 65 and older will increase from 4.1% to approximately 20% by 2050. A thorough
understanding of the neurobiological factors that contribute to age-related cognitive decline will not only provide
a mechanistic understanding of aging, but will also provide key avenues for therapeutics to minimize the negative
effects of aging on memory and reduce risk for AD. Aging results in both impaired synaptic function in the
hippocampus, a brain region critical for memory formation, and reductions in activity of the proteasome, the
catalytic component of the ubiquitin-proteasome system (UPS) that controls most protein degradation in the
brain. Decreased proteasome activity has been reported in aged tissue across organisms, including rodents and
humans, and is associated with AD. Further, our group has provided strong evidence for a role of proteasome
activity in memory formation and has collected preliminary data demonstrating that proteasome function is
already decreased in middle-aged animals, before memory impairments are typically present. This suggests that
proteasome downregulation precedes, and is likely a major contributing factor to, age-related memory
impairments like those observed in AD. However, due to technical limitations, whether ameliorating these deficits
in proteasome function can prevent or reverse age-related memory decline remains unknown. To address this
gap in the field, we recently developed a novel CRISPR-dCas9 approach to persistently stimulate proteasome
activity in specific brain regions of adult animals. Using this approach, the goal of this proposal is to test if
increasing proteasome function in the hippocampus can ameliorate age-related memory impairments and
associated pathophysiology. Aim 1 will test if increasing proteasome activity in the hippocampus of aged animals
rescues age-related memory deficits, reduces neuroinflammation, and restores the normal learning-related
degradation-specific proteome. Aim 2 will test if increasing proteasome activity in the hippocampus of young and
middle-aged animals can prevent age-related memory deficits, increases in neuroinflammation, and
dysregulation of the learning-related degradation-specific proteome at aged time points. Collectively, these
results will provide critical insight into whether reversing proteasome dysregulation later in life or preventing
proteasome dysfunction early in life can prevent or reverse age-related memory impairment.

Public health relevance
Project Narrative Using a validated rodent aging model and sophisticated genetic techniques, the proposed experiments will expand the current literature on the physiological underpinnings of age-related memory decline like that observed in Alzheimer's disease. Enhanced understanding of the biological mechanisms underlying aging-associated memory loss is important not only for increasing our basic knowledge of this process but also for the potential translation of research findings to understanding and treating age-related memory decline in humans.